Genomic and Computational Biology Support for NIDCD Intramural Research

Goals and Objectives

The NIDCD/NIDCR Genomics and Computational Biology Core provides support for developing cutting edge sequencing technologies to NIDCD and NIDCR investigators on a collaborative basis. The GCBC prepares sequence-ready libraries from investigator-supplied RNA or DNA samples, performs QC analyses and sequencing reactions, and analyzes the data in collaboration with investigators. NIDCD and NIDCR investigators are charged for reagent costs of library preparation and sequencing only. The NIDCD/NIDCR GCBC will also archive the data and assist investigators in uploading the necessary data files to a suitable public archive, in compliance with their Institutes Genome Data Sharing (GDS) policy.

Summary Fiscal Year 2022

In FY22, the GCBC worked with 14 different principal investigators from the NIDCD and NIDCR on 56 separate projects. These included RNA-seq at both single cell and tissue level, spatial RNA-seq, long read IsoSeq, whole-exome and whole-genome variant detection and epigenetic studies. In all projects the GCBC participated in experimental design, library production, sequencing and the bioinformatic analyses of the data. In addition, the GCBC helped to deposit data in public repositories when appropriate, and aided researchers in retrieving and analyzing publicly available genomic data.